The Brain Health Registry for facilitating interdisciplinary aging research

ABSTRACT
The overall goal of this proposal is to optimize and automate our existing online platform for recruitment,
screening, and longitudinal monitoring of elders to accelerate interdisciplinary clinical aging research. This will
be accomplished using the Brain Health Registry (BHR), an online registry and cohort with over 62,000
participants enrolled. The BHR collects longitudinal cognitive, health, and lifestyle data using self- and study
partner-report surveys and neuropsychological tests. The BHR platform has been used by many collaborators.
We will expand platform capabilities, optimize for efficient deployment in research settings, and automate manual
steps for scalability. We will facilitate the work of multiple clinical researchers by providing them user friendly
access to the BHR website, software and data. Specific Aims:
1. Study Partner First: Currently an innovative online BHR tool collects study partner (SP) information, but an
enrolled BHR participant must nominate a SP to join. We will develop and deploy SP-First to allow SPs to be
recruited de novo and for the SP to be the first or only point of contact with BHR. This will facilitate recruitment
and engagement of older adults into BHR and eventually into other Alzheimer’s disease (AD) studies and clinical
trials.
2. Referrals: To optimize and automate our current system which has referred over 27,000 BHR participants to
clinical AD and aging studies, including clinical trials and observational studies. This will greatly increase use of
this program, with the overall goal of facilitating recruitment and screening for AD and aging clinical studies.
3. Co-enrollments: To optimize and fully automate our current system for enrolling existing clinical cohorts in
BHR with data linkage. We will automate the co-enrollment process for investigators to enable efficient, scalable,
and adaptation of the tool for multiple aging studies. Co-enrollment can facilitate validation of online methods,
and is likely to improve longitudinal engagement and retention of participants in in-clinic studies.
4. Software as a Service (SaaS): BHR licenses the BHR platform as a software service to collaborators who
will create their own registries or referral programs under their own IRB, removing the need to create new registry
platforms. We will automate the SaaS process to facilitate highly scalable use by many investigators.
5. Data Sharing: To automate the process of data linkage, creating datasets, enabling highly scalable data
access, and data distribution. De-identified data from the general BHR study data will be made available to the
research community. A novel interface will allow investigators to query the database, create customized
datasets, upload and download data. In addition, we will expand and automate the capability to collect biofluids
for biomarker and genetic testing, and to integrate biofluids data into the BHR database.
Our innovative, highly-scalable platform will be of great value to investigators by providing them with user-friendly
internet tools for recruitment, assessment and longitudinal monitoring of their cohorts.

Public health relevance
NARRATIVE This project will optimize and automate the Brain Health Registry platform to support online recruitment, screening, assessment, and longitudinal monitoring of older adults. The software will be made available to many outside investigators for use in their own studies. Therefore, the innovative, highly-scalable platform that we will develop will facilitate and accelerate interdisciplinary clinical aging research by many clinicians studying cognitive aging and other neuroscience questions.